Microbial Contributions to Arsenic Transformation in the Gut

ABSTRACT (Project 3: Pawel Kiela, Paul Carini, and Albert Barberán)
Legacy mine tailings that remain after extraction of economic metals are frequently enriched with co-occurring
contaminants such as arsenic (As) that pose serious health hazards to neighboring communities and
ecosystems. As-ingestion has been associated with diabetes, numerous cancers, and cardiovascular
disorders. The mode of action for As toxicity is not clear; however, the degree of toxicity is associated with the
valence and the methylation state of As metabolites (e.g. trivalent As species, iAsIII, MMAIII, and DMAIII ,are two
times more cytotoxic than iAsV; methylated pentavalent arsenicals are 10-fold less cytotoxic than AsV). The gut
microbiome is a primary point of contact for As in the host because oral ingestion is the principal exposure
route. In addition, in vitro studies have demonstrated the capacity of human colon microbiota to biotransform
iAs to both more and less toxic forms. Thus, accurate As risk assessment requires understanding of
presystemic contributions by the gut microbiome to the bioaccessibility and speciation of the host As-load. The
overall objectives of this proposal are to 1) contextualize the composition of the mouse gut
microbiome with its functional capacity to metabolize As and to 2) evaluate the capacity of defined As-
transforming microbial communities to affect in vivo diabetic outcomes following As exposure. The
multidisciplinary team will employ a unique approach to identify specific associations between the composition
of the gut microbiome, its genetic and functional capacity to sequester and/or transform As, and its capacity to
either exacerbate or mitigate host diabetic outcomes in response to As exposure. Routine microbial taxonomic
(16S rRNA gene amplicon profiling) and functional gene (shotgun metagenome) analyses will identify the
impact of host sex, age and As-exposure on mouse fecal community composition. This molecular analysis will
be combined with function-based high throughput culture analysis of the same fecal communities to facilitate
the design of 120 distinct synthetic microbial communities (SynComs). The functional capacities of each
SynCom to transform/sequester iAs will be identified and will potentially capture emergent properties of
microbially-mediated As biotransformation that might be missed in studies using isolated phylotypes. The
SynComs will be clustered in functional guilds with differing capacities to increase or decrease the As-load
experienced by the host. These SynComs will be tested in germ-free mice to evaluate the capacity of specific
microbial consortia with distinct As biotransformation capacities to modulate diabetic outcomes of As exposure.
It is hypothesized that microbial communities that reduce As toxicity and associated diabetic outcomes can be
exploited as potential probiotics. This hypothesis will be tested through verification of the ability of positive-
outcome SynComs to colonize a specific pathogen free (SPF) mouse host and prevent or reduce pro-diabetic
effects of iAsIII exposure.

Public health relevance
NARRATIVE (Project 3: Pawel Kiela, Paul Carini, and Albert Barberán) Arsenic ingestion has been associated with diabetes, numerous cancers and cardiovascular disorders. Biotransformation of oral arsenic ingestion by the gut microbiome has potential to modulate the arsenic-load experienced by the host, and thus, must be incorporated into the risk assessment of arsenic ingestion. Microbial communities that reduce presystemic arsenic-toxicity can be exploited as potential probiotics to reduce negative health outcomes that are associated with chronic arsenic exposure.